Targeted therapies to correct genomic instability in Brca1-deficient cells.

Project Abstract: Targeted therapies to correct genomic instability in BRCA1-deficient cells. Individuals with mutations in either the BRCA1 or BRCA2 gene account for approximately 5- 10% of all breast cancers in the developed world. For women carrying a mutant BRCA1 gene, there is a nearly 80% lifetime chance of developing breast cancer and a nearly 40% chance of developing ovarian cancer. At present, there are no effective or targeted molecular therapies that modify this susceptibility. In the absence of BRCA1 activity, cells are incapable of repairing DNA breaks through the homologous recombination pathway (HR). HR provides an error free mechanism to repair DNA damage, but in the absence of efficient HR, cells can repair DNA damage though other error-prone pathways. The use of these pathways can lead to the formation of abnormal and potentially harmful chromosomal structures that promote tumorigenesis. Indeed, it is generally believed that the inability of BRCA1 deficient cells to perform HR is central to its role in tumor formation. Recent reports have demonstrated that it is possible to restore HR activity in BRCA1 deficient cells by deletion of the gene for the DNA damage response factor, 53BP1. These results suggest that in BRCA1-deficient cells, 53BP1 may act as a molecular inhibitor of HR. Furthermore, inhibiting 53BP1 activity may reduce the incidence of BRCA1-mediated breast cancer. The proposed research will explore the novel notion that it may be possible to restore near normal HR activity in BRCA1 cells and tissues. The interplay between 53BP1 and BRCA1 will be further characterized to refine our understanding of the underlying mechanism, as well as an attempt to develop lead compounds that inhibit 53BP1 function. A fuller understanding of this phenomenon will lead to targeted therapies to reduce the lifetime risk of tumor formation in BRCA1 and potentially BRCA2 carriers.

Public health relevance
Project Narrative: Targeted therapies to correct genomic instability in BRCA1-deficient cells. The subject of this study is BRCA1-deficient breast cancer. Depending on ethnicity, between 0.5% and 8.3% of breast cancer cases are associated with mutation in the Breast Cancer Associated 1 (BRCA1) gene. Women who carry mutations in BRCA1 have a particularly high risk of developing breast (estimated 57% lifetime risk) or ovarian (40% lifetime risk) cancers. Although BRCA1 mutation is not a feature of the majority of breast cancer cases, patients with BRCA1 mutations have earlier onset of disease and a high incidence of the 'triple negative' phenotype which carries a poor prognosis. There is presently no targeted therapy that significantly impacts the rate of tumor development for individuals carrying an inherited susceptibility for breast cancer. The recent development of PARP inhibitors that exploit the absence of homologous recombination (HR) activity in BRCA1 and BRCA2 -mutant cells represents an enormous step forward in targeted therapy, however, an even more effective strategy would be to prevent or delay the development of tumors in the first place. Somatic cells that have no functioning BRCA1 allele are defective for HR, leading to a failure to properly repair DNA damage and a propensity for further genomic instability that promotes tumorigenesis. The restoration of HR activity in BRCA1 deficient cells and tissues has generally been viewed as clearly advantageous, as it would prevent genomic instability in cells lacking BRCA1 function. However, restoring HR has also been assumed to be impossible, based on the known requirement of BRCA1 for HR. Recent data challenge this long held assumption by demonstrating a near total recovery of HR activity in BRCA1 deficient cells that contain the simultaneous deletion of 53BP1. Furthermore, in vivo mouse data show that this restoration of HR activity in BRCA1 deficient tissues significantly reduces the incidence of breast cancer. The goal of this proposal is to exploit these paradigm-shifting observations. Using mouse genetics to find DNA damage response factors that influence the use of the error-free HR pathway, new targets for clinical intervention in cancer will be found. The proposed research will also aim to identify small molecule inhibitors that prevent 53BP1 binding to chromatin, thereby restoring HR function in BRCA1-deficient cells and reducing the risk of tumorigensis. These agents will be lead compounds for an entirely novel approach to treating BRCA1 deficiency, based on preventing tumorigenesis by restoring HR function in BRCA1 deficient cells. __SpecificAimsTextDelimiter__ Specific Aims This study focuses on BRCA1-deficient breast cancer. Women who carry mutations in BRCA1 have a particularly high risk of developing breast and ovarian cancer with early onset and poor prognosis (Johannsson et al., 1997; Chen and Parmigiani, 2007). Absence of BRCA1 activity results in an increase in genomic instability, because BRCA1 is required for repair of double stranded DNA breaks by the error-free homologous recombination (HR) pathway. When HR is defective, cells depend instead on the non-homologous end-joining (NHEJ) pathway (Venkitaraman, 2002; Bunting et al., 2010). NHEJ is an error-prone pathway with a tendency to promote aberrant joining of DNA breaks, which is thought to be a major driver of genomic instability that leads to tumor formation. Recently, I showed that the defect in homologous recombination in a mouse model of BRCA1-deficient breast cancer is highly dependent on the presence of p53 Binding Protein 1 (53BP1) (Bunting et al., 2010). This finding suggests that it may be possible to restore homology-dependent repair by manipulating components of the DNA damage response and thereby prevent onset of BRCA1-deficient breast cancer. I hypothesize that use of error-prone DNA repair pathways causes genomic instability that leads to cancer. I will test this hypothesis by conducting studies into the factors and mechanisms that influence choice of cellular DNA repair pathways, as follows: Specific Aim 1: Define the factors that regulate DSB repair choice in BRCA1-deficient animals. Deletion of 53BP1 restores error-free DNA repair by HR and suppresses tumorigenesis in BRCA1-deficient cells. I will use mouse genetics to extend these observations by: a. testing whether 53BP1 deletion can reverse genomic instability in mice lacking other factors that are required for HR (for example, BRCA2); b. defining which other factors in the same pathway as 53BP1 affect genomic instability in BRCA1-deficient cells. These experiments will reveal the interplay between DNA repair pathways, and demonstrate which DNA damage response factors can be targeted to modulate DNA repair. Specific Aim 2: Define the functional domains of 53BP1 required for repression of HR. The mechanism by which 53BP1 inhibits HR is not known. Using knock-in mice and mutagenesis constructs with deletions in the 53BP1 gene, I will test which of the known protein domains of 53BP1 participate in antagonizing DNA double-strand break resection and HR. These experiments will reveal how 53BP1 is regulated, and the importance of its interactions with other factors of the DNA damage response. Specific Aim 3: Use high throughput screens to develop candidate small molecule inhibitors of 53BP1 and test whether they can rescue HR in cells lacking BRCA1 activity. 53BP1 binds to chromatin through an interaction of its Tudor domain with a specific histone mark. I plan to use a high-throughput screen to find small molecule inhibitors of 53BP1 that could be used as a basis for developing drugs that reverse the negative effect of 53BP1 in BRCA1-deficient cells. These experiments are expected to reveal small molecule inhibitors of 53BP1 that restore error- free DNA repair by HR in BRCA1-deficient cells. By completing these experiments, I will find new mechanisms to modulate toxic DNA repair pathways to prevent genomic instability and cancer predisposition caused by BRCA1 deficiency. Ultimately, it is envisaged that this data will form the basis for future clinical studies using human patients with mutations in BRCA1.